Immunologic Mechanisms and Rheumatic Diseases

This continuation of an established program emphasizes the techniques and concepts of cell and molecular
biology, genetics, computational biology, musculoskeletal (limb) regenerative medicine and fundamental
studies of immunology relevant to rheumatic, autoimmune and musculoskeletal diseases. Original population-
based clinical research employs rigorous methodological design and statistical analysis. Support is requested
for 6 postdoctoral trainees with an M.D., a Ph.D., or both, and for 1 predoctoral (Ph.D candidate) trainee. The
faculty are carefully selected and perform research in areas of: I) Basic Biology including, 1) Adaptive
Immunity (B and T Cell Biology), 2) Innate immunity, 3) Musculoskeletal (Limb) Regeneration and 4)
Computational Biology, and II) Translational and Clinical Research including 1) Animal Models of
Rheumatic and Musculoskeletal disorders, 2) Human Immunology and Genetics of Rheumatic Disease and 3)
Patient-Centered Research in the Epidemiology and Outcomes of Rheumatic and Orthopedic Diseases. While
the primary strength of the program resides in the direct and individual nature of the interaction in the
laboratory between each trainee and the responsible faculty member(s), substantial didactic experiences, the
medical school and university environments, along with a series of structured activities foster interactions and
supplement training. Trainees audit semester courses at Harvard Medical School in their field of basic
science, while population science investigators obtain an MPH or a similar degree at the Harvard School of
Public Health. Postdoctoral trainees in a combined clinical and research training program join this program
after completing their clinical training. Graduate students join the program only after completing course work
and are in Harvard Ph.D Programs in Biomedical and Biological Sciences including (1) Immunology and 2)
Bioinformatics and Integrative Genomics. The program is hosted in the Division of Rheumatology,
Immunology and Allergy at Brigham and Women’s Hospital. Importantly, approximately 40% of faculty are part
of the program but located in other divisions, departments and Harvard Medical School affiliated Institutions
and are selected for their relevance to the program goals and their outstanding scientific and training expertise.
Besides Brigham and Women’s Hospital Departments of Medicine, Orthopedics and Neurology, they include
faculty at 1) the Broad Institute of Harvard and MIT, 2) Boston Children’s Hospital, 3) Massachusetts General
Hospital, 4) Harvard Medical School Departments of Immunology, Biomedical Informatics, and Genetics, 5)
Harvard University Department of Stem Cell and Regenerative medicine, and 6) the Harvard School of Public
Health. The program goal is to provide an ongoing pipeline of highly trained and expert investigators
prepared for and focused in rheumatic and related musculoskeletal disease research.

Public health relevance
Project Narrative The Division of Rheumatology, Immunology and Allergy at Brigham and Women’s Hospital and this training grant vehicle provide the core that integrates basic and translational investigators across Harvard-affiliated institutions working in areas of basic biology, and translational and population sciences relevant to and focused in musculoskeletal and autoimmune rheumatic disease. Its goal is to provide an ongoing pipeline of select, highly trained and expert investigators prepared for and focused in rheumatic disease research.